Epigenetic mechanisms of histone methyltransferase ASH1L in autism spectrum disorder

Project Abstract
ASH1L (Absent, Small, or Homeotic discs 1-Like) is a histone methyltransferase facilitating gene expression
through its-mediated chromatin modification. Recent genetic studies on large cohorts of autism spectrum
disorder (ASD) patients identify ASH1L is one of top ASD risk genes. The genetic findings are further supported
by many clinical reports that children diagnosed with ASD acquire various de novo ASH1L mutations. To
understand the pathogenic role of disruptive ASH1L mutations in ASD pathogenesis, we used the Ash1l
conditional knockout (cKO) mice to show that deletion of Ash1l in the mouse brain was sufficient to cause autistic-
like behaviors and cognitive memory deficits, suggesting that disruptive ASH1L mutations are likely to be
causally involved in ASD genesis. Our following studies showed that Ash1l-KO mice developed general neural
hyperactivity, suggesting that loss of ASH1L causes excitation/inhibition (E/I) imbalance of neural signals in the
brain. Furthermore, our recent study reported that postnatal administration of SAHA, a histone deacetylase
inhibitor, ameliorated core autistic-like behaviors and cognitive memory of Ash1l-deficient mice, suggesting that
histone acetylation and ASH1L-mediated histone modification have a synergistic function in maintaining normal
brain functions. Building upon these discoveries at the molecular, brain, and organismal levels, we propose that
ASH1L facilitates gene expression through its-mediated histone modification in the brain. Loss of ASH1L impairs
the expression of genes critical for maintaining E/I balance in the brain, which consequently leads to neural
hyperactivity and behavioral deficits in Ash1l-KO mice. To further investigate the epigenetic mechanisms of
ASH1L in ASD pathogenesis, we will used the Ash1l-cKO mice to examine the function, transcriptome, and
epigenome of cortical excitatory neurons, inhibitory neurons, and astrocytes in the brain. Specifically, we will (1)
dissect the functional roles of three neural lineages in contributing to the neural hyperactivity and behavioral
deficits in Ash1l-KO mice; (2) examine lineage-specific transcriptome dynamics to identify genes involved in the
functional abnormalities of the Ash1l-deficient brain; (3) examine lineage-specific epigenome dynamics to identify
ASH1L-mediated epigenetic mechanisms involved in the functional abnormalities of the Ash1l-deficient brain.
Completion of this study will not only significantly advance our understanding of the ASH1L-mediated epigenetic
mechanisms in regulating gene expression in the brain and their pathogenic roles in ASD genesis, but also
potentially lead to the development of new therapeutic approaches to treat the ASH1L-mutation-induced
neurodevelopmental diseases.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) is a clinically heterogeneous neurodevelopmental disorder that is associated with various gene mutations, including ASH1L (Absent, Small, or Homeotic discs 1-Like) gene that encodes a histone methyltransferase with its function in facilitating gene expression through epigenetic modification of chromatin. To understand the epigenetic mechanisms underlying ASH1L’s function in ASD pathogenesis, we will use an Ash1l-knockout-induced ASD mouse model to examine the function, transcriptome, and epigenome of cortical excitatory neurons, inhibitory neurons, and astrocytes in the mouse brain. The success of this project will not only largely advance our understanding of basic epigenetic mechanisms in autism pathogenesis, but also potentially lead to the development of new therapeutic approaches to treat ASD.